Mentoring and Patient-Oriented Research in Mind and Body Practices

Over the past 17 years Dr. Natalia Morone established her research career in patient-oriented research (POR)
and integrative nonpharmacological interventions to treat chronic pain, particularly mindfulness interventions
for chronic low back pain (cLBP). Her research portfolio also extends into mindfulness delivered via electronic
Health (eHealth) and telehealth. She has an established record of research, publications, teaching, and
mentoring. Her KL2 award and R01 focused on integrative treatment for cLBP and her R34 expanded into
mindfulness eHealth for hypertension. Her current UH3 award seeks to translate mindfulness for the
treatment of cLBP into the clinical setting via a pragmatic clinical trial. She mentors medical students,
residents, fellows, post-docs, and junior faculty. Mentees have gone on to receive federal grant funding, have
published their work in peer-reviewed journals and have presented their work both locally and nationally.
Working with the pipeline of the future biomedical research workforce is critical to training the next generation
of complementary and integrative medicine (CIM) investigators. She has a long-standing commitment to
fostering the careers of underrepresented groups (URGs) in research and is currently the multi-PI of a U-award
to retain URGs in research through the evaluation of a 12-month career development intervention. There is a
growing evidence base that mind and body practices are effective treatment for chronic medical conditions.
Yet implementation into clinical practice has not widely occurred. Electronic health approaches may also
facilitate integration of mind and body practices into the clinical setting. This award will be key to providing the
dedicated protected time necessary for expanding the candidate's research and increasing her mentoring
capacity in the implementation of mind and body practices for chronic medical conditions and harnessing
technology to facilitate engagement of patients in these practices. She will leverage the Boston University
Clinical and Translational Science Institute's (BU CTSI) rich resources for training, education, and supporting
research to ensure the success of her mentees. The project Aims are to: 1. Implement mind and body practices
for chronic medical conditions into clinical care. 2. Harness technology to deliver mind and body practices
for chronic medical conditions. 3. Mentor and train the next generation of integrative medicine investigators
in rigorous mind and body practices in patient-oriented clinical research. The K24 research projects will
expand Dr. Morone's research into implementation science and eHealth. This proposal has been developed to
provide a rich source of research projects for mentees that will develop the pipeline of researchers in POR and
CIM and advance the field of mindfulness for chronic medical conditions through implementation science and
eHealth. The abundant resources of the BU CTSI will be a necessary component to mentoring. Dr. Morone has
devoted over 8 years to increasing the diversity of URGs in research and this will continue to be a focus of her
mentoring for this award.

Public health relevance
There is a growing evidence base that mind and body practices are effective treatment for chronic medical conditions. Yet implementation into clinical care has not widely occurred. Electronic health approaches may also facilitate integration of mind and body practices into patient care. This award will be key to providing the dedicated protected time necessary to expand the candidate's research and increase her mentoring capacity. Her research and mentoring will expand into the implementation of mind and body practices for chronic medical conditions in clinical care and into electronic health to facilitate patient uptake of theses practices.